Innovative medical device to treat nonunion fracture for older adults

Abstract
Bony fracture is one of the most challenging musculoskeletal injuries in the elderly population.
In clinic, a significant decline in bone healing potential, accompanying with mental and life-
threatening complications, is commonly observed in elderly who are 65 years or older. With the
rapid growth of elderly population in the US, it imposes a substantial cost burden on the health
care system to treat fracture. Although significant advances have been made in developing
therapeutic approaches (bone graft materials, growth factors and stem cells) for fracture repair,
there is still unmet clinical need for new approaches to treat delayed fracture healing or fracture
non-union, especially for elderly patients.
To fulfill this effort, we have focused on angiogenesis, which has long been considered as a key
initial step during fracture healing to re-establish blood supply for delivery of oxygen, nutrients,
and cells. Particularly, recent studies have illustrated that due to the inflammaging in elderly
patients, chronic inflammation adversely affects angiogenesis, and in turn results in the failure of
bony callus formation and develops delayed union or non-union. In this regard, we provide
evidence that systemic inflammation results in impaired angiogenesis and fracture non-union in
mice. Mechanistically, angiogenesis defect mediated by inflammation is at least partially due to
down-regulation of CXCL12 (C-X-C Motif Chemokine Ligand 12) and exogenous CXCL12 can
restore angiogenesis capacity in vitro. In order to apply CXCL12 to local fracture treatment
while avoiding excessive angiogenesis or other side effects in other tissues, we design to
deliver CXCL12 locally by FDA approved PCL material. The PCL/CXCL12 material display
similar biomechanical properties compared to periosteum and a controlled slow-release pattern
of CXCL12. More importantly, local delivery of CXCL12 shows a robust angiogenesis process
and a restoration of fracture union in mice under systemic inflammation conditions. The
overarching goal of this STTR proposal is to pursue the commercialization of this biodegradable
and release controllable PCL/CXCL12 material as a potential therapeutic treatment to promote
fracture healing, especially in elderly patients.

Public health relevance
Delayed union and non-union are frequently observed in the aging population. The goal of the study is to develop a device that can promote fracture healing to improve the health of older adults.